A role for hypothalamic astrocytes in neural circuits controlling reproduction

PROJECT SUMMARY
Astrocytes are a glial subtype that are essential for numerous central nervous system functions. Dysregulation
of astrocyte function is known to cause a variety of neurological and neuromuscular disorders. Interestingly,
disruption of hypothalamic astrocytes has the capability to compromise fertility. Roughly one in five couples in
the USA suffer from some type of infertility, thus elucidating the complete circuits underlying reproduction is
essential. Gonadotropin-releasing hormone (GnRH) neurons in the preoptic area and hypothalamus form the
final common pathway for the central control of fertility. Pulsatile GnRH secretion causes release of luteinizing
hormone (LH) and follicle-stimulating hormone (FSH) from the anterior pituitary, activating gonadal functions
including steroidogenesis. An afferent network likely governs pulsatile GnRH secretion, including both steroid-
sensitive kisspeptin neurons in the arcuate nucleus (KNDy neurons) and glia. Although pulsatile GnRH release
is common to male and female reproduction, females exhibit unique processes including reproductive cycles
and ovulation that could alter neural-glial interactions. Critically, astrocytes exhibit morphological plasticity and
the levels of hypothalamic neuron ensheathment by glia change across cycle stages, pointing to potential
astrocytic regulation that varies with respect to cycle stage. Astrocytic mediators like prostaglandin E2 (PGE2)
can also regulate GnRH neuron activity, and PGE2 is required for timely sexual maturation and adult
reproduction in rodents. To investigate the contexts in which astrocytes regulate reproductive neural circuits, a
combination of electrophysiology, calcium imaging, and glial cell cultures will be used. Aim 1 will study if factors
including sex, cycle stage, and time of day influence the ability of astrocytes to regulate GnRH and/or KNDy
neuron firing rates. In vitro chemogenetic activation of astrocytes via the transduced Gq signaling receptor
hM3D(Gq) will be employed to induce intracellular calcium transients that typify endogenous Gq-induced
astrocyte activity, while monitoring the activity of identified neurons. In Aim 2, chemogenetic activation of
primary astrocyte cultures followed by high-performance liquid chromatography of supernatants will be done to
elucidate the gliotransmitter profiles of hypothalamic astrocytes. To compliment this, the endogenous Gq-
coupled receptor profiles will be assessed in glial cultures and brain slices transduced with GFAP-GCaMP6f
via treatment with candidate Gq ligands. These results will inform my subsequent experiments in which an
endogenous Gq-coupled receptor will be knocked down in hypothalamic astrocytes and a gliotransmitter
receptor in GnRH neurons, providing a test for the necessity of these components of glial-neural signaling for
reproduction in vivo. Completion of the proposed work will clarify roles of astrocytes in the neuroendocrine
control of fertility. Elucidating the mechanisms by which astrocytes communicate back-and-forth with GnRH
and KNDy neurons will pave the way to identifying potential therapeutic targets to treat types of infertility.

Public health relevance
PROJECT NARRATIVE Hypothalamic astrocytes form a core, yet incompletely understood, component of the neural circuit underlying reproduction. This project will interrogate to what extent astrocytes regulate elements of the reproductive control circuit and the mechanisms by which astrocytes and neurons residing in this circuit communicate. The findings of this proposal will further our understanding of the mechanisms underlying typical reproduction and may point to novel therapeutic targets for treatment of infertility.